Community reentry for older adults leaving prison with and without health limitations

ABSTRACT/SUMMARY
Older adults are the fastest growing segment among incarcerated populations. The vast majority of
older adults currently serving time in US prisons are men and racial/ethnic minorities, particularly Black men.
Older adults in prison are a medically vulnerable group as time spent in prison amplifies and introduces new
disease burdens due to highly restrictive environments and scarce resources. People in prison consistently
report declines in health. Compared to the general population, older adults in prison have greater health
limitations such as problems with mobility, cognitive impairment, polypharmacy, multiple comorbidities, and
geriatric conditions, which can threaten their ability to live independently. These health challenges create
burdens not only on correctional systems but also to the communities where these individuals will return.
People returning to the community from prison face formidable challenges and the inability to reintegrate
successfully into community living is one of the main drivers for recidivism. Yet, little is known about the health
status of older adults leaving prison and how it impacts their transition during this critical reentry period. It is
known that older adults leaving prison will face greater challenges than their younger counterparts but existing
studies have not examined the added risk of having health limitations. Older adults may be returning to
environments characterized by limited access to healthcare resources and caregivers, unstable housing, and
challenging financial and family circumstances, particularly if incarceration was lengthy and social support
systems have deteriorated over time. Poor health may compound these existing challenges. The specific aims
of this study are to: (1) investigate the factors and disparities associated with successful reentry among older
adults leaving prison (N=80); (2) elicit narratives about health, social, and community factors that impede or
facilitate reentry among older adults with health limitations (N=30); and (3) adapt findings for a reentry case
management program to develop specific modules to meet the needs of older adults leaving prison. Findings
will be adapted to the evidence-based intervention, Project START+, a reentry case management model
developed by members of the research team. Our study is innovative in that we study the critical reentry period
for a medically vulnerable, high need, but under-characterized population. Research questions and hypotheses
are theoretically grounded and results will provide practical findings for implementation. As a result of this
project, we will develop an intervention that can be tested with future funding. The partnership with the
Wisconsin Department of Corrections and Wisconsin Community Services, the largest community-based
organization in Wisconsin that provides reentry services for people leaving prison, is a key strength.

Public health relevance
NARRATIVE Incarcerated older adults may face multiple health challenges that pose as barriers to successful reintegration upon release from prison. An interdisciplinary research team, in partnership with the Wisconsin Department of Corrections and Wisconsin Community Services, seeks R21 funding to investigate the risks to reentry posed by health limitations. We will recruit older adults leaving prison with and without health limitations to assess and compare their reentry trajectories, challenges, and successes upon leaving prison and returning home.